PHASE3 CLINICAL TRIAL OF TRAMETES VERSICOLOR IN WOMEN WITH BREAST CANCER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this project is to better understand the role mushroom extracts play in protecting the immune system.